KARYOLOGY AND PROGNOSIS OF HUMAN MALIGNANT MELANOMA

Karyology and immunology have all been demonstrated in various tumor systems to provide useful prognostic information. This proposal will combine studies of all three in a clinically relevant, statistically sound approach to determine if these laboratory tests will indeed be useful prognostic markers for malignant melanoma.